NHP Resources for SARS-CoV-2/COVID-19 Countermeasure Development

To generate NHP resources for use to gain in-depth understanding of SARS-CoV-2 infection across multiple species and determine the relative efficacy of candidate countermeasures.